Professional Development

Leveraging the past success of Harvard Medical School’s (HMS) four major teaching hospitals and basic
science departments, the Professional Development Core (PDC) will focus on preparing trainees for a smooth
entry into the program and supporting them with a series of resources and individualized opportunities to
optimize research and career development experiences within the program. This Core will produce a tailored
combination of formal programs, seminars, and networking events, and personal interactions with faculty and
other trainees including opportunities for introduction to and acquisition of data analytic and other technical
skills integrated with an online informational and learning hub. Trainees will be exposed to and explore
complementary sciences and technologies through intentional interactions with peers and mentors in other
research areas, creating multiple cross-discipline opportunities. These interactions are designed to inspire
innovation and promote entrepreneurship. The PDC will support the ongoing development and training of
trainees and mentors through the following Aims. Aim 1: Coordinate the selection of trainees, composition
of Individual Oversight Committee (IOC) and Individual Training Plans (ITP). The PDC will adopt a
structured approach to assist trainees in project and mentor selection, and in formation of the IOC. Emphasis
will be placed on trainee educational goals ensuring an individualized training experience, and an ITP will be
created with input from mentors, trainees, and technical experts. Formal evaluative tools will be used to
monitor trainee experiences, trainee progress and mentor effectiveness which will inform the evolution of the
overall program. Aim 2: Develop and present specific course curricula, interactive events, and materials
to enhance trainee education. In collaboration with the Network Core, the PDC will develop new didactic
experiences in areas important for the immediate and long-term success and competitiveness of academic
researchers with an introductory KUH minicourse, twice monthly seminar series and annual retreat. These will
benefit from input from the Industry/Entrepreneurism Council and Patient Input Council. The Core will also
leverage existing Harvard ecosystem resources summarized on the HKUHTI web Hub to ensure training in
scientific writing, mentoring and team science. Aim 3: Provide technical electives that reduce barriers for
incorporation of state-of-the-art technologies into trainee career development. The PDC will offer a
variety of curated opportunities to facilitate trainee competence in data analytics and large databases, as well
as exposure to novel technology platforms to enhance training in cross-disciplinary research. These
interactions will enhance the trainee’s professional network and create opportunities for interdisciplinary
connections among Kidney, Urology and Hematology disciplines. The PDC will work closely with other Cores
to develop multi-disciplinary trainees at various stages of career development with a deep passion for
innovation and team-based KUH research.